Re-purposing Oncolytic Virotherapy to Re-invigorate CAR T Cell Therapy for Solid Tumors.

PROJECT SUMMARY
Efficacy of CAR T cell therapies against solid tumors has been limited by a lack of expansion in vivo, low levels
of tumor trafficking, poor functionality/persistence and by suppression in the tumor micro-environment (TME).
Conventionally prepared CAR T cells are unable to retain sufficient differentiational plasticity to undergo natural
pathways of T cell proliferation/differentiation/persistence in vivo for sustained, effective cytotoxic anti-tumor
activity. Oncolytic viruses (OV) selectively replicate in tumor cells to generate a highly inflammatory TME
which may enhance CAR T cell recruitment to, and function within, solid tumors. Our goal is to develop a novel
regimen by which oncolytic virotherapy can be used as a potent immunological adjuvant to improve the
efficacy of CAR T cell therapy against solid tumors.
By loading the OV on the CAR T cells ex vivo, we achieved highly significant improvements in tumor therapy
compared to virus or CAR T cells alone. Mice treated with completely systemically delivered CAR T and VSV
developed a population of CD8+ CAR T cells with T Cell Receptor (TCR) specificity for the immunodominant
H2Kb VSV N52-59 epitope of VSV which selectively expanded in vivo to very high frequency. This population of
dual-specific (DS) (virus-specific and CAR T antigen-specific) memory-like (TM) CAR T cells 1). persisted in
mice for much longer than conventional CAR T, 2). was significantly more functional against tumor, and 3).
could be rapidly re-activated in vivo against tumor by a secondary systemic boost with homologous virus,
resulting in long-term tumor cures. These therapeutic effects were observed with two different OV (VSV and
reovirus) and across tumor sites (subcutaneous and intra-cranial). Therefore, here we propose a completely
novel approach to expand the scope of CAR T cell therapy against solid tumors in which dual specific CAR T
cells with improved activity against tumors are generated by using co-administered OV to induce a
recapitulation of the physiological pathways that lead to optimal (CAR) T cell activation, proliferation and
differentiation in vivo in response to virus infection.
We have formulated three Specific Aims: 1) To define the molecular mechanisms by which TCR engagement
of DS CAR T cells determines their phenotype, improved persistence and function; 2) To generate in vivo
expanded populations of DS CAR T cells with TCR specificity against either tumor associated, or viral recall,
antigens and to determine their therapeutic activity against established tumors; 3) To optimize in vivo
expansion, persistence/longevity and re-activation of DS CAR T cells through novel boost and rest strategies
targeting either the TCR, CAR or both. This will lead to implementation of fully systemic protocols for the
combination of CAR T cells with OV which do not require any access to tumors.

Public health relevance
PROJECT NARRATIVE This research project will develop a novel regimen by which oncolytic virotherapy can be used as a potent immunological adjuvant to improve the efficacy of CAR T cell therapy against solid tumors. We have shown that CAR T cells loaded ex vivo with oncolytic virus (OV) induces a population of CAR T cells with dual specificity against the CAR target tumor antigen and oncolytic viral antigen(s) in vivo, which have improved memory-like differentiation, persistence, and greatly enhanced anti-tumor potency compared to conventional CAR T cells. In this proposal, we will now 1). define the molecular mechanisms of DS CAR T cell generation; 2). generate DS CAR T cells with TCR specificity against either viral, or tumor associated, antigens and 3). optimize the persistence/longevity/activity of DS CAR T cells through novel boosting strategies, leading to implementation of fully systemic protocols for the combination of CAR T cells with OV which do not require any access to tumors.